Creating Pb Risk Mitigation Using Source Apportionment in an EJ Community

Abstract
East Trenton, NJ is an environmental justice (EJ) community burdened by lead (Pb). Pb is a cumulative
environmental toxicant that can affect multiple organ systems including the central nervous system. Current
public health guidelines state there is no safe level of Pb exposure. This project’s priority is to reduce Pb
exposure to residents. Partnering with three local community organizations, Isles Inc, East Trenton
Collaborative, and New Jersey Future, community volunteers will conduct citizen science collecting soil
samples from homes throughout the East Trenton neighborhood. Concurrently, Rutgers, ETC, and NJ Future
will host community clinics to offer free blood Pb testing to concerned residents. While no resident will be
turned away, a special emphasis will be placed on collecting blood samples from children. A home visit
(minimum 100 homes) will be conducted in any home that tested above 200 ppm soil Pb (50% EPA residential
soil Pb hazard level) or with a resident’s blood Pb level >0.5µg/dL. Drinking water, paint, soil, and house dust
will be collected and analyzed for Pb isotope ratios and metal-to-metal ratios (e.g., Ti/Pb, Sb/Pb, Ga/Pb, etc.).
Bayesian mixing models will be created using this tracer data to conduct source apportionment that will identify
unique fingerprints for lead sources in blood and house dust. Home specific mitigation strategies will be
developed using data from these mixing models that are specific to the unique sources of lead identified in the
home environment. If a lead paint abatement is required, our community partner (Isles, Inc.) will conduct the
lead paint abatement. Other mitigation strategies, (eg ground cover for exposed soil, entry way dust collecting
mats to trap street dust) will also be recommended and a follow up visit to these 100 homes will be conducted
6 months post-mitigation to test the efficacy of the recommended mitigation strategies. During this visit, blood
and house dust samples will be collected to determine if there was a decrease in exposure. Finally,
dissemination of results will occur through town hall style community presentations and written reports will be
provided to our community partners. This project is valuable because it will develop a playbook that can be
used as an intervention model for other lead burdened communities on developing personalized abatement
strategies available by adding source apportionment to the toolbox for exposure assessment.

Public health relevance
Project Narrative East Trenton is an environmental justice community that bears a disproportionate burden of lead exposure in addition to low income, high population of less than high school education, and large minority population. This project’s goal is to identify lead exposure pathways within this community using citizen science, providing risk reduction strategies, and testing their efficacy. This project is a potential model for mitigating exposure risk in other lead burdened communities.